2022 Optics and Photonics in Medicine and Biology Gordon Research Conference and Seminar

PROJECT SUMMARY
The 2022 Gordon Research Conference (GRC) on Optics and Photonics in Medicine and Biology continues
the 55-year proud history of the GRC on Lasers in Medicine and Biology. This GRC is one of the highest rated
meetings indicating the quality of the program and the inclusive community. The 2022 conference brings new
life to this longstanding meeting with a focus on biophotonics research spanning the full spectrum from basic
biology to clinical medicine. An emphasis throughout the conference this year will be on data science, linked to
the theme of the Gordon Research Seminar (GRS), a forum to enhance the GRC experience of graduate
students and postdoctoral fellows.
This conference will bring together an outstanding and diverse group of scientists at the forefront of
biophotonics research to stimulate discussion and exchange of ideas. All speakers are encouraged to present
new, unpublished research in the tradition of the “off the record” policy of the GRC. The intimate environment
provides a unique experience for researchers across all levels to engage in scientific discovery.
The mission of the conference is directly in line with the mission of the NIH to improve health by leading the
development and accelerating the application of biomedical technologies. In particular, this year's conference
is focused on technology and application that is used to advance basic research and medical care. Biomedical
imaging is a primary focus of the meeting, particularly the development of optical imaging technologies to
improve the detection, diagnosis, and treatment of disease. Photonic technologies enable biomedical research
at multiple scales spanning organ level imaging to molecular level sensing.
A primary goal of this conference is the professional development and support of junior scientists. This
proposal requests funding to support the registration and travel costs of early career investigators, post-docs,
and graduate students to attend the GRC and GRS to be held at Bates College in Lewiston, Maine.

Public health relevance
PROJECT NARRATIVE The 2022 Optics and Photonics in Medicine and Biology GRC is the premiere meeting for senior, junior, and student researchers in the fields of biophotonics, biomedical optics, and biomedical imaging to share current research trends and future research directions to improve human health. The meeting will cover research in light-based technologies applied to the full spectrum spanning basic biology to clinical medicine with a focus on applications of data science to biomedical imaging.